Mechanism of F. nucleatum in intrauterine infection

Intrauterine infection is a major cause of pregnancy complications. Fusobacterium nucleatum (Fn), a gram-negative common oral anaerobe, is one of the most prevalent species in intrauterine infection. Fn can translocate hematogenously from the mother’s mouth to her uterus as a result of dental bacteremia. Using a pregnant mouse model developed in the PI’s laboratory, we have shown that once blood borne, Fn translocates specifically to the mouse placenta without causing systemic infections. The pattern of Fn colonization in the mouse placenta mimicked that in humans. Fn stimulated murine placental inflammatory responses resulting in fetal demise. Placental inflammation and fetal loss were diminished in Tlr4-/- mice even if the bacteria could still colonize. These results demonstrate inflammation is the underlying cause of fetal loss. The consistency between the observations in humans and in mice validates the use of the pregnant murine model to study the pathogenesis mechanisms of Fn. We propose a single-aim study: To investigate the pathogenesis mechanisms of Fn in pregnant mice. Results from this study will significantly substantiate our understanding of the mechanisms of intrauterine infection and identify therapeutic targets to protect pregnant women and their fetuses. Furthermore, this study will shed novel lights on how oral bacteria impact infections and inflammation at extra-oral sites.

Public health relevance
Intrauterine infection is a major cause of pregnancy complications such as preterm birth and stillbirth. Fusobacterium nucleatum (Fn), a common oral bacterium, is one of the most prevalent species in intrauterine infection. Using a highly integrated and state-of-the-art approach, we will analyze the pathogenesis mechanisms of Fn in intrauterine infection to identify potential targets to treat and prevent intrauterine infection. Results from our study will have profound impact on our understanding of this devastating infectious disease and patient management. Moreover, it will shed novel light on how oral bacteria impact infections and inflammation at extra-oral sites.